Cre-driver rat resource project R24

PROJECT SUMMARY
This R24 resource grant will leverage our existing infrastructure: personnel, expertise in rat transgenesis and
gene editing, high throughput strain development and characterization, cryopreservation and rederivation, and
distribution channels resulting in an economy of scale to generate novel and important Cre-driver rat models
for the research community through the following three aims. Aim 1) Establish the utility of existing Cre-driver
rat models of potentially high biomedical research interest. Models already created by others in the field with
particularly high value to multiple investigators, but with lack of characterization data will be imported and
initially validated by crossing with a Cre-sensitive fluorescent reporter model to characterize the on-target and
off-target tissue specificity and reproducibility of each model. Another goal of Aim 1 will be do develop and test
new Cre-sensitive reporter strains with bioluminescent reporters to allow in vivo imaging of Cre-driver activity.
Aim 2) Develop additional Cre-driver and floxed gene model strains to broadly impact the research community.
We will solicit applications from the community of rat model investigators in the field to create and characterize
additional high value, novel transgenic Cre-driver models for tissues relevant to multiple research investigators.
Investigators may also propose to develop a floxed gene model critical to their studies. An externally led
scientific review process will be used identify the largest need and most broadly useful models for
development. Models will be developed using cutting edge approaches and characterized as in Aim 1. Aim 3)
Gather Cre-driver strain data under one community supported Cre-driver rat resource to be hosted by the Rat
Genome Database. Data collected in Aims 1 and 2 and from Cre models developed and published by other
research groups will be curated by our team and hosted in the Rat Genome Database to establish a one-stop
searchable Cre-driver rat resource portal. Together, these aims to characterize and develop new Cre-driver rat
strains and collect and share all models and data in a single Cre-driver rat data resource will benefit the broad
research community using this species by identifying the models which are most needed, filling gaps in
research areas lacking these tools, and developing these models in a cost-effective way to establish a critically
lacking set of tools for these researchers.

Public health relevance
PROJECT NARRATIVE This R24 resource grant utilizes our capabilities for high throughput transgenic model development to develop novel transgenic rat models to be used to broadly study normal biology, physiology, and disease mechanisms. These transgenic models will allow for the manipulation of genes and other transgenes in a tissue- and/or time- dependent manner. Collectively, this resource of genetic tools will be very useful to the broad research community that uses laboratory rats to study gene function in a wide variety of behavioral and physiological studies.